Basement membrane self-assembly and structure

Abstract: Basement membranes (BMs) are extracellular matrices (ECMs) containing laminins, collagen-IV,
nidogens and proteoglycans as structural elements. They provide mechanical support for cells and act as
signaling platforms. Laminins mediate BM assembly by adhering to cells, by establishing cytoskeletal links
through receptors, by polymerizing, and by recruiting the other BM components. These cell-adherent ECMs
are essential for tissue growth, differentiation, and maintenance, attributes that depend upon BM molecular
architecture and receptor-binding. Diseases of BMs can result from structural changes that adversely affect
muscle, peripheral nerve, kidney and other organs. The long-term goal of the grant is to elucidate mechanisms
of BM assembly and architecture-dependent functions. This goal is critical for understanding BM disease
pathogenesis and for developing therapies for BM defects. We now seek to determine how BMs can be modified
to regain lost function in neuromuscular and renal diseases, explore the molecular basis of laminin
polymerization, and elucidate architectural properties of BMs that determine functions.
Aim I. Mutations ablating the polymerization laminin α2 subunit result in ambulatory muscular dystrophy
(LAMA2-MD) with peripheral nerve amyelination. We succeeded in ameliorating the muscle component of a
mouse (dy2J) model of polymerization-deficient dystrophy by transgenic muscle expression of a laminin-
binding linker-protein called αLNNd. This leads us to evaluate this protein for repair of the peripheral nerve
component of the disease. The aim holds potential for development of a therapy by viral somatic gene delivery.
Aim II. Proteins conferring polymerization (αLNNd) and dystroglycan (αDG) receptor-binding (miniagrin,
mag) to laminins have been used to ameliorate the severe muscle disease resulting from absent laminin-α2
(dy3K mice). The benefit results from modification of compensatory α4 laminin that otherwise neither
polymerizes nor binds to αDG. Normal assembly and functions of α4-laminins will be explored, focusing particularly on
peripheral nerve myelination. We plan to complete an analysis of transgene muscle expression in the dy3K
mouse, and evaluate αLNNd and mag in Lmα2-null peripheral nerve to determine if this ameliorates the
paresis. The aim is expected to elucidate laminin contributions needed for myelination and contribute to
development of a therapy to treat muscle and nerve in LAMA2-MD arising from total loss of the α2 subunit.
Aim III. BM-binding proteins can be engineered to alter BM assembly and functions by increasing receptor
binding, inducing polymerization, and altering inter-component binding and spacing. We propose to use these
unique reagents to determine if the human laminin mutations that cause dystrophies and renal Pierson
syndrome are due to failures of laminin polymerization, to map the polymerization residues on laminin LN domain
surfaces accompanied by a structural analysis of the polymer node, probe the separate roles of laminin and
collagen-IV polymers on cells, and evaluate inter-laminin spacing of the polymer in determining functions.

Public health relevance
Project Narrative Basement membranes are cell-adhesive scaffolds and agonists that are required for tissue growth, differentiation and adult functions. Elucidation of the underlying mechanisms of assembly, structure and functions is critical to understand the pathogenesis of basement membrane-dependent diseases of kidney, nerve, muscle, other organs, to develop structure-based therapies, and to engineer biomaterials with basement membrane properties for tissue regeneration and repair.